Quantifying Physiologic and Pathologic Viscoelastic Phases of Biomolecular Condensates by Correlative Force and Fluorescence Microscopy

SUMMARY
Dynamic, membrane-less compartmentalization of subcellular processes via biomolecular condensation is
ubiquitous in living systems. Mounting evidence suggests biomolecular condensation is driven by complex, multi-
component phase transitions that combine liquid-liquid and liquid-solid transitions. During the past five years,
the PI has made key contributions to the field by connecting the physics of viscoelastic materials to biological
functions of condensates and uncovering mechanisms and regulation of phase transitions in multi-component
biomolecular condensates with direct implications in neurodegenerative disorders as well as cancer. Addressing
these challenges required advancements in technologies, specifically in quantitative measurements of
condensate material properties. The PI developed optical tweezer-based nanorheology that enabled direct
probing and rational engineering of condensate material properties at nano-to-micron length-scales and µs-to-
ms timescales. These studies showed that protein condensates are metastable fluids with time-dependent
viscoelastic properties that are sequence and structure-specific and are altered by disease mutations. However,
we do not understand how material properties and aging dynamics of multi-component condensates are
regulated in living cells. Are the molecular driving forces underlying physiological phase separation and
pathological maturation of protein condensates distinct and separable? What are the molecular rules of selective
co-condensation of disordered transcriptional proteins? Importantly, although almost all current models of
biomolecular condensation are protein-centric, evidence suggests RNAs play important roles in the form and
function of cellular condensates. However, the molecular driving forces of RNA-driven phase transitions and their
link to the regulation of RNA granule biology are poorly understood. The goal of this proposal is to address these
critical knowledge gaps in the next project period. Leveraging our new view of condensates as viscoelastic fluids,
we propose to answer a set of highly relevant and challenging questions that have the potential to transform our
understanding of the biophysical mechanisms, function, and disease processes mediated by biomolecular
condensates. Our research will address three Key Challenges (KCs): we will (a) probe the condensate
microenvironment and physical aging in live cells by multi-parametric fluorescence lifetime-based imaging and
nano-rheology (KC 1); (b) map RNA phase separation coupled to percolation in single and multi-component
condensates and test our hypothesis that RNA binding proteins act as chaperones against irreversible RNA
percolation (KC 2); and (c) detect, quantify, and manipulate sequence-specific grammars in disordered prion-
like domains encoding selective protein-protein interactions between transcription factors, coactivators, and
chromatin remodeler complexes (KC 3). Our studies will provide new insights into the determinants of functional
co-condensation, dynamics, and composition as well as identify new pathways of their pathologic transformation.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it seeks to develop a rigorous conceptual, experimental, and computational framework for understanding the form and function of liquid-like biomolecular assemblies in living organisms. Using our framework, we will study the mechanisms of selective biomolecular condensation and the material properties of such assemblies formed by disease-linked RNA and protein molecules, particularly in the context of neurodegeneration and cancer.